Role of ATII cell senescence in influenza pathogenesis in aging

Alveolar type II (ATII) cells synthesize, secrete, and recycle surfactant proteins and lipids and regulate alveolar lining fluid
depth by alveolar fluid clearance. Because both processes require large amounts of energy, ATII cells contain large numbers
of mitochondria and mainly generate ATP by oxidative phosphorylation (OXPHOS). ATII cells are the primary site for
influenza A virus (IAV) replication in the distal lung and central players in the pathogenesis of IAV-induced ARDS.
Importantly, the elderly are over-represented in influenza-related fatalities. However, there is limited understanding of the
impact of either aging or IAV infection on ATII cell function, senescence, and energy metabolism. ATII cells isolated from
lungs of young (2-3 month-old) C57BL/6 mice primarily generate ATP by OXPHOS. In contrast, preliminary studies show
ATII cells from aging (27 month-old) mice undergo a glycolytic shift and downregulate OXPHOS, possibly as a result of
senescence. IAV infection of young mice causes a glycolytic shift and a decrease in OXPHOS which is reversed by CDP-
choline treatment, resulting in a net increase in total ATP production, attenuated hypoxemia, and reduced pulmonary
inflammation. IAV infection of aging mice causes more severe hypoxemia and further reduces OXPHOS without any
compensatory increase in glycolysis, resulting in a net decrease in total ATP production despite the increased energy
demands imposed by viral replication. Hence, it is hypothesized that influenza is more severe in the elderly because IAV
infection imposes additional energetic demands for viral replication on ATII cells that lack inherent metabolic flexibility
due to aging-associated senescence. By inhibiting de novo phospholipid synthesis, IAV also induces further mt dysfunction.
Together, these effects provoke an energy crisis and render ATII cells unable to perform their normal physiologic functions
(alveolar fluid clearance and surfactant synthesis), which results in progression to ARDS. It is further proposed that CDP-
choline treatment improves OXPHOS in ATII cells and increases their functional capacity, thereby improving influenza
outcomes. This hypothesis will be tested in two Specific Aims. Aim 1 will use a robust, reproducible, and relevant model
of IAV-induced ARDS in 21-24 month-old C57BL/6 and BALB/c mice to define effects of aging, IAV infection, and CDP-
choline treatment on ATII cell physiologic functions (surfactant production and alveolar fluid clearance), whole body
metabolism (by open circuit calorimetry), lung glucose uptake (by PET/CT), lung inflammation, and viral replication. Aim
2 will use a comprehensive battery of flow cytometric assays and Western blot to quantify the level of senescence in ATII
cells isolated from the lungs of mock- and IAV-infected young and aging mice and will analyze the impact of aging, IAV
infection, and CDP-choline treatment on ATII cell energetics by extracellular flux analysis. Proposed experiments will
provide novel mechanistic insights into the contribution of ATII cell dysfunction and senescence to development of more
severe influenza in the elderly and will generate fundamental new information relevant to many pulmonary diseases of
aging, such as COPD, IPF, and non-small cell lung cancer.

Public health relevance
Statement of Relevance to Public Health Influenza A virus causes a highly contagious acute respiratory disease. Seasonal influenza epidemics cause >300,000 deaths/yr worldwide and severe disease and death are more common in the elderly. Although much is known about how aging impacts the immune response to influenza vaccination and infection, much less is known about how aging-associated changes in respiratory epithelial cell function contribute to increased influenza severity in the elderly. Proposed studies will provide insights into this question, with a goal of identifying new host-directed therapeutic targets to ameliorate severe influenza in older patients.